Myo-inositol regulation of myelination in development and hypoxic newborn brain injury

Project Summary
No change from parent award.

Public health relevance
Project Narrative No change from parent award.